Combining Pregabalin with Lofexidine: Can it Increase the Success of Transition to Naltrexone?

Extended-release naltrexone (XR-NTX) reduces overdose risk and is filling a niche for opioid addicted
patients that do not want agonist maintenance or cannot access it. However transitioning to naltrexone
requires detoxification, which is a major hurdle. Methadone or buprenorphine tapers are effective but require a
7 to 14-day opioid-free interval before starting naltrexone, leaving ample time to relapse. Non-opioid
detoxification with an alpha-2 adrenergic receptor agonist may shorten the time, and lofexidine was recently
approved for this indication. It is safer than clonidine however like clonidine, it does not reduce the subjective
effects of withdrawal and patients do not like it. A medication that better targets these symptoms may improve
outcomes and increase the proportion that transition to XR-NTX. Pregabalin may be such a medication. It
potentiates the activity of glutamic acid decarboxylase, inhibits calcium influx and release of excitatory
neurotransmitters, raises GABA levels, and is approved for neuropathic pain, fibromyalgia, adjunctive therapy
for adults with partial onset seizures and in Europe, for anxiety. It was not controlled in Russia for several
years but was placed on their equivalent of our Schedule V due to reports that opioid addicted persons were
using it to reduce withdrawal and abuse. Based on this information, Krupitsky and colleagues randomized 34
consenting, heroin-addicted inpatients under double-blind conditions to pregabalin or clonidine-based
detoxification protocols. More pregabalin than clonidine patients completed detoxification (p = 0.01) and
pregabalin patients had better retention than clonidine patients (p = 0.001) with no differences in adverse
events.
Here we propose to see if pregabalin can be combined with lofexidine to better reduce the subjective
effects of opioid withdrawal than lofexidine, and increase the proportion that transition to XR-NTX. Such a
dosing combination could lower the detoxification hurdle for patients who are interested in antagonist treatment
or who are in settings where it is unavailable or difficult to access. This work will require two phases, and both
fit into the UG3/UH3 announcement. In UG3 we will study pregabalin/lofexidine combinations to identify one
that reduces withdrawal-related subjective effects without generating more serious adverse events than
lofexidine alone. In UH3 we will test that combination in an adequately powered trial to determine if it
increases the number of patients that complete detoxification and transition to XR-NTX. Hypotheses are that
we will identify a dosing combination that is safe and reduces opioid withdrawal to a greater degree than
lofexidine alone, and that this lofexidine/pregabalin combination will result in more patients completing
detoxification and transitioning to XR-NTX. The ultimate goal is to generate data to support new or modified
indications(s) and/or inclusion of new recommendations in product prescribing information to improve
detoxification outcome and increase the proportion that transition to XR-NTX

Public health relevance
PROJECT NARRATIVE This study aims to identify a pregabalin/lofexidine combination that decreases the dysphoria and other subjective effects of opioid withdrawal and increases the proportionof patients that makethe transitionfrom opioid addiction to antagonist treatment with its overdose prevention and other beneficial effects.